Translational Reprogramming by Regulatory T Cells

Project Summary Regulatory T cells (Tregs) play an indispensable role in maintaining immunological tolerance to self-antigens and in suppressing excessive immune responses deleterious to the host by exerting a suppressive program towards a wide variety of target immune cells. However, the intracellular molecular events that mediate such suppression in target cells in still poorly understood. In this study, we will investigate the molecular nature of this suppression program with the central hypothesis that regulation of the translational machinery and specific mRNA translation control is at the core of this reprogramming event. We will utilize a novel genetic tool that allows immunopurification of ribosomes in virtually any immune cell type in both in vitro and in vivo immune models called “RiboTag.” Using RiboTag, we will capture the genome-wide translatome (all mRNAs being translated in time and space) during Treg-dependent immunological tolerance breakdown. We will further investigate the mechanism of such mRNA transcript-specific translation control with the hypothesis that the trans-acting translation regulatory protein factors are modulated in target cells encountered by Tregs. The RiboTag mediated immunopurification of ribosomes followed by mass spectrometry based proteomics will delineate such changes in the riboproteome (the ribosome itself or ribosome-associated factors) endowed by Treg encounter in target cells. These studies will break new ground in understanding a novel layer of gene expression control imposed by Tregs, a critical component in our immune system essential for immunological tolerance.

Public health relevance
Project Narrative The immune system uses a variety of approaches to prevent self-reactivity and subsequent autoimmune disease. Among these are central tolerance, involving the negative selection and death of developing T cells in the thymus expressing self-reactive TCRs, and peripheral tolerance, carried out by a specialized subset of CD4 T cells, referred to as regulatory T cells (Tregs) capable of suppressing the activation of effector T cells. The mechanism by which Tregs perform this function is largely unknown. The studies in this proposal are designed to test the hypothesis that Tregs suppress T cell activation by altering mRNA translation in target cells. Testing this novel hypothesis will provide new insights into Treg biology and unveil a new pathway for therapeutic intervention.